Linking Lipoxygenases with Essential Fatty Acids and Epidermal Barrier Formation

DESCRIPTION (provided by applicant): The long-term objective of this application is to elucidate the roles of two lipoxygenase (LOX) enzymes and their essential fatty acid (EFA) substrate in forming the water impermeable barrier of the epidermis, defects in which result in ichthyoses and contribute to atopic dermatitis. 12R-Lipoxygenase (12R-LOX) and Epidermal Lipoxygenase-3 (eLOX3) are the only human lipoxygenases that, if mutated to inactive forms, result in a disease, a form of autosomal recessive congenital ichthyosis (ARCI). The fact that the characteristic scaly skin of ARCI is also manifest in essential fatty acid (EFA) deficiency, suggests a possible substrate-enzyme relationship between EFA and the two LOX enzymes. We will test a new hypothesis that connects EFA, 12R- LOX and eLOX3, and the structure of the epidermal water barrier. We propose that the two lipoxygenases oxygenate a critical form of EFA, linoleate esterified to the omega-hydroxyl of the very long chain fatty acid of the unique epidermal acylceramides. We further propose that this oxygenation is required to facilitate hydrolysis of the (oxidized) linoleate moiety and leave the very long chain fatty acid omega-hydroxyl free for coupling to the cross-linked proteins of the corneocyte envelope, a vital step in sealing the water barrier. The Specific Aims are (1) To characterize 12R-LOX and eLOX3 activity in the epidermis in vivo using animal models, (2) To assess the efficacy of LOX products and ceramides in rescuing the phenotype in murine LOX-/- models, (3) To characterize 12R-LOX and eLOX3 activity in human epidermis including in ARCI patients, and (4) To characterize the putative oxidant-sensitive step of acylceramide ester hydrolysis. The results of this study wil piece together an important facet of construction of the epidermal water barrier and allow a rational approach to the use of oxidized linoleate and its analogs for future therapeutic interventions in the LOX- dependent classes of ichthyoses. If the physiology of the barrier is properly understood, this constitutes a firm foundation for the rational design of any barrier-related therapeutics, and it is to rationalize the role of these well-known key components of the epidermal water barrier that is the main goal of this project.

Public health relevance
PUBLIC HEALTH RELEVANCE: The scaly skin diseases of ichthyosis afflict families with inherited mutations in skin enzymes that are normally involved in keeping the skin watertight. This study seeks to clarify how lipid enzymes called lipoxygenases are involved in forming this water barrier. Understanding this will help explain how other enzymes cooperate in the process and allow for rational treatment of the ichthyoses.